Neural Dynamics of Fear Circuits in Ecological Rodent Models of Risk and Trauma

PROJECT SUMMARY
For over a century, Pavlovian fear conditioning paradigms have been pivotal in studying basic associative fear
memory formation through conditioned stimulus (CS) pathways, significantly enhancing our understanding of
fear- and anxiety-related disorders in humans. However, given that the brain's fear system may operate
differently under real-world risks, it is essential to explore neural dynamics and behavioral outcomes within
ecologically relevant scenarios.
This application proposes to utilize our established 'approach food-avoid predator' paradigm in rats to investigate
the primary fear circuit mechanisms involved in risky decision-making within spatial environments featuring
lifelike agents of danger. This approach leverages how the biologically-primed innate or unconditioned stimulus
(US) pathways process and adapt to potential and actual attacks.
Aim 1: We will test the hypothesis that the amygdala functions as a pivotal relay, processing biological threat
information from the midbrain and transmitting fear signals to specific corticolimbic structures, thereby guiding
risky goal-directed decisions. This investigation will thoroughly examine the dynamics of predatory pathways
among the periaqueductal gray, amygdala, hippocampus, and medial prefrontal cortex, spanning anatomical,
neurophysiological, and causal dimensions.
Aim 2: We will characterize the changes in midbrain-corticolimbic mechanisms resulting from a singular life-and-
death event—a nociceptive shock to the dorsal neck/body during evasion from a predatory threat—that cause
generalized, nonassociative fear responses. These observations could yield insights into post-trauma-like
avoidance behaviors.
Our research has dual significance. Firstly, it enhances foundational knowledge from fear conditioning paradigms
that emphasize CS pathway-mediated learned fear responses by offering a broader perspective on fear
mechanisms incorporating US pathway-mediated innate and nonassociative fear responses. Secondly, it
integrates dynamic agent-induced trauma perspectives relevant to interpersonal threat conditions. This
comprehensive approach holds the potential to advance treatments for trauma disorders, particularly those
stemming from assaults.

Public health relevance
PROJECT NARRATIVE Fear is a fundamental mechanism that allows animals to evade predators in their habitats and enables humans to protect themselves from interpersonal threats in society. This research will employ ecologically-relevant 'approach food-avoid predator' paradigms to explore the neural dynamics of fear circuits that guide purposive behaviors—integrating navigation, decision-making, and vital actions—in real-world scenarios where threats from animate entities are often ambiguous. By deepening our understanding of the brain's fear response to biological dangers, both potential and actual attacks, we can develop more effective treatments for trauma disorders arising from spousal and child abuse, combat experiences, and other forms of assault.